SEROTONIN, IMPULSIVITY AND TYPE II ALCOHOLISM

The aim of this experiment is to examine the relationship between the serotoninergic system in young male adults at risk for early onset alcoholism and impulsiveness/aggressiveness. At-risk subjects and matched controls will undergo a procedure that depletes brain levels of tryptophan, the rate limiting step in the synthesis of serotonin. We hypothesize that at-risk subjects will exhibit greater impairment on a measure of response inhibition following this manipulation compared to a placebo session and control subjects.